Child Neurologist Career Development Program

Project Summary / Abstract
Disorders of the developing nervous system are common, affecting roughly 15% of the population. To improve
the lives of children (and adults) with such disorders, we are in critical need of an enhanced pipeline of child
neurology physician-scientists who will drive the innovative research necessary to lead to improvements in
prevention, diagnosis and intervention. We propose, in this renewal application for the Child Neurologist
Career Development Program (CNCDP-K12), to build upon our extant program, providing intensive, mentored
career development for pediatric neurologists committed to being independently funded physician-scientists. This
NINDS funded program is the nationalized version of the Neuroscience Academic Development Award (NSADA),
a program granted to individual institutions. While the NSADA supported the research career development of
numerous child neurologists, the program has under-delivered at the national level, as measured by the
number of funded scholars to receive individual K awards, arguably due to its yoking to up to 10 specific
institutions. By contrast, the CNCDP has a single Program Director with an Executive Leadership comprising 8
highly collaborative physician-scientist pediatric neurologists who are national leaders in the discipline. The CNCDP
has 2 faculty committees: a 15 member Scientific Advisory & Review Committee (SARC) and a 4 member National
Advisory Committee (NAC). The faculty members comprising these committees, all accomplished physician-
scientists with over 25% from non-pediatric neurology disciplines, have diverse sets of expertise. The SARC reviews
scholar applicants/applications and serves as extra-institutional advisors. The NAC provides to the leadership
ongoing critical evaluation of the program. Under the CNCDP, individual pediatric neurologists (within 3 years of
completion of clinical training) from any academic institution in the US can apply. The applicant must demonstrate
a high quality and feasible research project, a robust career development plan, and institutional environment
supportive of physician scientist career development, and an institutional letter of support committing appropriate
protected time to research and career development. The Annual Meeting, a 2.5 day retreat attended by all faculty,
funded scholars, applicants, NIH staff, and others, constitutes a mechanism for intensive mentoring and career
development through small group sessions, one-on-one meetings, scholar presentations of their work (with
intensive focus on quality presentations and articulating specific aims), and other career-enhancing curriculum.
Program curriculum is also provided year-round through webinars/video conference. At the Annual Meeting,
the SARC reviews the applications and recommends typically 6 of the most meritorious for 3 years of funding. A
total of 30 scholars (90 scholar-years) are to be funded. The CNCDP provides highly structured oversight of the
scholars' progress as well as institutional and scholar commitment to the program's requirements. Success of
the program will be measured by a high rate of both scholars and non-funded applicants achieving individual K
level funding or the equivalent.

Public health relevance
Project Narrative This career development program will prepare child neurologists who have recently completed clinical training to become independently funded physician scientists. The program will support 30 such recently minted child neurologist scholars with 3 years of funding and a robust curriculum that enhances and complements the scholars' institutional resources, and also provides curriculum and support for the non-funded applicants. Success with this program will lead to the needed enhancement of the number of child neurology physician-scientists doing the research necessary to more effectively address the very common problem of developmental disorders of the nervous system.